Effects of the oral environment on KSHV shedding in Ugandan adults living with HIV

Project Summary/Abstract
In sub-Saharan Africa (SSA), Kaposi’s sarcoma-associated herpesvirus (KSHV), the etiological agent of
Kaposi’s sarcoma (KS), is endemic and HIV incidence is high making KS one of the most common cancers in
adults associated with high mortality, even in the antiretroviral therapy (ART) era. Although oral lesions are
common among AIDS-KS patients, the effects of HIV infection on the oral environment and KSHV reactivation
in the oral cavity before KS development are completely unknown. Using innovative and validated techniques
this study will be the first to test the hypothesis that alterations in the oral environment during HIV infection are
a critical determinant of KSHV reactivation and increased KSHV shedding in the oral cavity. I propose a large
adequately powered longitudinal study of 600 Ugandan adult males and females followed over two years from
three groups: people living with HIV (PLWH) on long term ART, newly diagnosed ART-naïve PLWH, and HIV
uninfected. Participants will be enrolled at the General Population Cohort (GPC) in rural Uganda where KSHV
seroprevalence is among the highest in the world and at The AIDS Support Organization (TASO) and AIDS
Healthcare Foundation (AHF) Uganda Cares, both longstanding HIV care clinics which serve the GPC area.
Oral health examinations will be completed to identify whether PLWH exhibit markers of oral disease including
gingivitis and periodontitis, resulting in increased KSHV reactivation and higher KSHV viral loads in saliva
(shedders). Oral fluids will be collected to identify whether higher oral inflammatory markers, and lower KSHV-
specific IgA are associated with oral KSHV shedding. To capture the role of HIV on changes causing oral
microbiome dysbiosis in the oral cavity and continued effects on oral reactivation and shedding of KSHV, we
will sequence the V1V3 regions of 16s rRNA, which gives high resolution power to differentiate species in the
oral microbiome. The findings produced by this study are truly unique and will be fundamental in identifying
whether markers of oral disease, oral mucosal inflammation, reduced immune control in the oral cavity, and
oral microbiome dysbiosis are factors leading to KSHV reactivation in the oral cavity prior to KS development.
There is an immense gap in the research with regards to the effects of oral health and the oral environment on
KSHV reactivation and KS development. We will incorporate an exceptional multi-disciplinary team of experts
with innovative and validated techniques to collect truly unique data on oral health and oral immune response
indicators from a rural population in SSA. The inventive direction of this proposal combined with the critical
need to identify effects of the oral environment on oral KSHV reactivation and shedding, information needed to
further the field of research on interventions and therapeutics for KS in PLWH, makes my proposal the perfect
fit for this Catalyst award. The information acquired will substantially expand our knowledge of factors driving
KSHV reactivation in the oral cavity before KS pathogenesis which is integral to identifying targets for
interventions against KS development in SSA in addition to other high-risk populations outside of SSA.

Public health relevance
Project Narrative In sub-Saharan Africa, where Kaposi’s sarcoma-associated herpesvirus (KSHV) seroprevalence and HIV incidence are highest in the world, the effects of the oral environment on oral KSHV reactivation and shedding in people living with HIV (PLWH) before Kaposi’s sarcoma (KS) development are unknown. We propose the first and largest longitudinal study to our knowledge that will assess the effects of oral health, oral environment, and the oral microbiome on KSHV reactivation and shedding in rural Ugandan adults living with and without HIV infection. We will leverage an experienced multi-disciplinary team, a strong study design, and innovative and validated research techniques to identify the effects of the oral environment on KSHV reactivation in PLWH, a profound knowledge gap integral to identifying pre-risk measures for oral cavity KS involvement and developing prevention tactics in the region most affected.